Tumor-Selective Radiosensitization by Targeting Hypoxia in Rectal Cancer

PROJECT SUMMARY
The paradigm for treatment of locally advanced rectal cancer (LARC) has shifted to total neoadjuvant therapy
(TNT), where preoperative chemotherapy and radiation therapy (RT) are delivered prior to surgery. Utilizing this
approach, pathologic complete response rates of ~30% have been reported. In addition, non-operative
management (NOM), where watchful waiting with serial imaging and endoscopic assessments are performed,
is possible in ~30-50% of patients who complete chemotherapy and RT. NOM allows patients to avoid a
potentially life-altering surgery, but local recurrence occurs in 25-30% of patients. Thus, about two-thirds of
patients ultimately require surgery due to ineligibility for NOM or failure after treatment for NOM. Innovative
treatment approaches are needed to enhance response rates to make NOM feasible in the majority of LARC
patients. One factor contributing to lack of response is tumor hypoxia, which has been shown to contribute to
radiation resistance in multiple cancer types including rectal cancer, but has not been effectively reversed to
date. Hypoxia-related resistance to radiation is particularly more noticeable in higher dose per fractions of
radiation. We have found that targeting mitochondrial oxygen consumption (MOC) can effectively sensitize
tumor cells to radiation therapy using an FDA-approved mitochondrial complex I (papaverine) inhibitor. In this
patient study, we will characterize the biology driving the response of LARC to standard of care (SOC) TNT
therapy with RT followed by chemotherapy, and determine if intervention with a mitochondrial inhibitor in this
context may represent a safe, and effective approach worthy of further investigation. In Aim 1, we will determine
whether papaverine (PPV) a mitochondrial complex I inhibitor can be safely combined with RT using a two-
cohort phase I study. This innovative study will incorporate a control cohort and a cohort combining PPV with
short course RT over 1 week, which employs a larger radiation dose per fraction than conventional radiation,
and thus stands to benefit most from hypoxia-directed strategies. We will also perform longitudinal collection of
tumor and normal rectal biopsies, and peripheral blood, (before, during, and after RT) in order to
comprehensively determine how papaverine and RT alters tumor molecular profiles and the immune contexture,
through transcriptomic, and tumor and peripheral (blood) compartment immune profiling. In Aim 2, we will test
whether treatment with PPV directly results in reduced tumor hypoxia. We will use state-of-the-art functional MR
imaging techniques to measure blood oxygenation and use our longitudinal tissue collections obtained during
the phase I trial to measure changes in established hypoxia gene expression signatures. In Aim 3, we will
examine the impact of papaverine in combination with radiation on the immune microenvironment. Results from
these studies will lead to a deeper understanding of the biological basis of response to radiation therapy for rectal
cancer, develop molecular and imaging biomarkers of response to therapy, and will rationalize the innovative
strategy of targeting hypoxia through a reduction in MOC in order to improve response rates in LARC.

Public health relevance
PROJECT NARRATIVE The current recommendation for patients with advanced but localized rectal cancer includes delivering chemotherapy and radiation therapy, both prior to surgical removal of the tumor. Some patients respond well to therapy while others do not, and for those who respond well, surgery and the accompanying changes in quality of life may not be necessary. We are investigating the potential of a drug which may enhance the effectiveness of standard therapy for rectal cancer and potentially increase response rates in order to avoid surgery, as well as develop a deeper understanding of the changes in the rectal tumor at the molecular level in patients receiving standard chemotherapy and radiation therapy.